NATURAL HISTORY OF HIV INFECTION IN A COHORT OF GAY/BISEXUAL MEN

Construct a data base and repository of specimens to be used by investigators studying the virus. The four clinical centers and the data center are collectively known as MACS (Multicenter AIDS Cohort Study).